A Computational Platform for In-Situ Structure Determination at Near-Atomic Resolution using Cryo-Electron Tomography

PROJECT SUMMARY
Understanding how proteins interact within the cell to perform specific functions is a major goal of modern
biology, and vital for understanding the diverse roles these molecules play in biomedicine. Cryo-electron
tomography (cryo-ET) combined with sub-volume averaging (SVA) is currently the only imaging technology that
allows imaging macromolecules within their unperturbed native environment at nanometer resolutions. Most
successful studies, however, have been of large complexes or supramolecular assemblies, and at resolutions
that are too low to reveal molecular level interactions. The overall objective of this Technology Development
project is to design computational tools to improve the resolution of cryo-ET/SVA and extend its applicability to
a wider class of biomedically relevant targets. The specific aims are: (1) we will develop strategies to improve
the accuracy of the tilted contrast transfer function determination from low-dose tomographic projections, (2) we
will design algorithms to improve the accuracy of sub-volume alignment, reconstruction and classification aimed
at reducing the computational B-factors associated with data processing, and (3) we will optimize imaging and
data processing parameters to enable high-resolution studies of a wider class of targets including small
complexes. As proof of principle, we implemented a first-generation prototype of our platform and tested it on
monodisperse samples imaged by cryo-ET. The preliminary results demonstrate that our platform: (1) improves
the state-of-the-art in terms of achievable resolution, and (2) can be used to determine the structure of a 300kDa
enzyme at 3.9 Å resolution, representing a ground-breaking achievement for the field. Our research is innovative
because it seeks to overcome fundamental technical challenges in cryo-ET needed to realize the full potential of
this emerging imaging technology. The proposal is significant because it will be the first demonstration that low-
molecular weight targets can be imaged at near-atomic resolution using cryo-ET, indicating that this technique
is the most promising route for imaging important biomolecules in-situ. Ultimately, by closing the “resolution gap”
between strategies for studying monodisperse samples at high-resolution (X-ray, NMR and single-particle cryo-
EM) and techniques to study proteins in their native environments, our methods will allow the visualization of
protein complexes in their functional state at unprecedented levels of detail.

Public health relevance
PUBLIC HEALTH RELEVANCE Cryo-electron tomography (cryo-ET) is an emerging imaging technique capable of elucidating the structure of proteins and protein-complexes of broad biomedical interest within the context of the cell. The development of computational methods to improve the resolution of structures determined by cryo-ET and sub-volume averaging will turn this technology into a powerful tool for studying important biomolecules in-situ. Our methods will contribute to broadening adoption of cryo-ET by adjacent disciplines in modern biology, accelerating biomedical research and providing more opportunities for the development of new medical treatments to combat disease.